Society for Developmental Biology Annual Meetings 2024-2028

Cho, Ken
PROJECT SUMMARY
Developmental biology focuses on understanding how an organism develops from a single totipotent cell
into a mature individual and encompasses the study of aging and reproduction. The SDB annual
meetings stand as the central meeting platform, drawing scientists and students devoted to the study of
developmental biology from around the World. The SDB meetings aim not only to advance the study of
developmental biology and related areas, but also to create a supportive platform for all researchers in
the field. Additionally, we are dedicated to educating a diverse audience, including principal investigators,
postdoctoral fellows, graduate and undergraduate students, and educators, about the ethical and social
issues surrounding the field, such as reproductive concerns and the inequality in science education
throughout the US.
Developmental biology has been advancing at a relentlessly fast pace. In recent years, there have been
amazing transformations in technologies and integration with mathematical, computational and physical
sciences, resulting in the adoption of multifaced, qualitative and quantitative approaches. The SDB
annual meetings have evolved with these shifts, consistently offering a platform for the latest
breakthroughs in developmental biology and biomedicine. These events bring together a diverse
community of scholars, fostering invaluable connections. The SDB mission is to educate the scientists at
the forefront of scientific advancements, nurture young scientists, and facilitate rich knowledge
exchanges between established and emerging investigators. Naturally, we are keen on bolstering our
society's commitment to diversity and inclusivity within STEMM.

Public health relevance
Cho, Ken PROJECT NARRATIVE The Annual Meetings of the Society for Developmental Biology are the major yearly event where top developmental biologists and trainees gather to discuss recent scientific advancements and offer educational training for new PIs, postdoctoral fellows and students. These meetings explore the mechanisms that guide the normal development of organisms post-fertilization and the outcomes when these mechanisms go awry. Unlike other meetings focused on specific organisms or diseases, the SDB annual meetings offer an integrated perspective on development, attracting researchers using various organisms and technologies.